CSHL Mechanisms of Eukaryotic Transcription Conference

Mechanisms of Eukaryotic Transcription In higher organisms including plants and animals, the genetic code (DNA) is to be found in an internal compartment of the cell known as the nucleus, tightly packaged into chromosomes in a DNA-protein complex called chromatin. Genes are expressed when messenger RNAs (mRNA) are copied off the DNA code in a process called transcription, before leaving the nucleus to be translated into proteins at "protein factories" called ribosomes. Transcription is now known to be a highly orchestrated process, with expression of sets of genes being turned on and off at various stages of the life of the organism. This international conference is intended to be a forum for discussion of the latest research in the field and to promote future progress in our understanding of this complex and fundamental biological process. This conference is notable because the majority of talks are selected from openly submitted abstracts giving ample opportunity for broad and diverse representation of junior scientists including graduate students to present their latest research. Funds will primarily be used to support junior scientists and members of under- represented constituencies within the field who would otherwise not be able to attend.

Public health relevance
The regulation of gene transcription is a prominent mechanism for the control of cellular processes and development. This has led a large but diverse group of scientists towards the study of transcription in numerous systems. The aim of the conference on Mechanisms of Eukaryotic Transcription is to provide a forum to bring together the diverse group of scientists working in different areas of this field. This meeting allows each of them to hear, discuss, and critically evaluate the latest results from different experimental systems and to form a global picture of mechanisms of gene regulation. The conference will be an open international meeting devoted to the most recent advances in the rapidly evolving field of eukaryotic transcription. Oral presentations will consist of a combination of invited presentations and selected presentations from submitted abstracts. This ensures the participation of junior and senior leaders in the field and the presentation of the most exciting results emerging at the time of the meeting. The oral presentations will be complemented by poster presentations in three poster sessions, also selected from submitted abstracts.